Ligand-mediated, vehicle-free delivery of small RNAs

PROJECT SUMMARY
Like the challenges and skepticism that faced the antibody therapeutics field over a decade ago, RNA
therapeutics is facing the same. And, like the antibody therapeutics field, we are beginning to realize the clinical
impact of RNA therapeutics amiss these challenges. This is most clearly highlighted with the recent approval of
two mRNA vaccines to prevent against SARS-CoV-2 and the first three FDA approved RNAi drugs targeted to
the liver. Unfortunately, RNA-based drugs targeted to cancer cells is lagging behind, even with countless years
of work that has revealed the power of using RNAi for treating oncological diseases. Lack of success in this
space is attributed to inability to deliver RNAi safely and effectively. We previously developed a method that can
safely deliver therapeutic microRNAs (miRNAs) to tumors that overexpress the folate receptor. However, the
anti-tumor response was short-lived due to instability of the miRNA and poor pharmacokinetics, necessitating
frequent dosing. To overcome these insufficiencies requires a stabilized miRNA that retains targeting activity.
Recently we screened a panel of fully modified versions of miR-34a (FM-miR-34a) and identified one with >400-
fold increased stability and outstanding in vivo efficacy when conjugated to folate. Treatment of mice implanted
with breast cancer xenografts with folate-FM-miR-34a resulted in complete cures in two out of six mice and
significant tumor regression in the remaining four. Based on this exciting data, here we propose to advance FM-
miR-34 forward in two ways. In Aim 1 we will evaluate the activity, efficacy, and safety profile of FM-miR-34a in
in vivo models of lung and prostate cancer. FM-miR-34a will be conjugated to: i) folate for delivery to lung cancer,
and ii) PSMA-617, a ligand that targets prostate specific membrane antigen (PSMA) for delivery to prostate
cancer. In Aim 2 we propose to capitalize on the stability afforded by FM-miR-34 to increase the circulation ½
time of folate-FM-miR-34 and PSMA-617-FM-miR-34a though incorporating an albumin binding moiety (ABM)
into the ligands. Using these ligands we will evaluate serum albumin binding and stability of the new ligands. We
will also verify that conjugation to ABM does not alter the activity of miR-34a nor cell binding and internalization
kinetics. Finally, we will assess in vivo distribution of ligand-ABM-miR-34a conjugates.
At the completion of this work we expect to have an all-encompassing miRNA delivery vehicle that can
target a stabilized tumor suppressive RNAs specifically to NSCLC and prostate cancer. We will also have new
ligands with increased circulation ½ life. The data obtained will ultimately have a significant impact in cancer
treatment by providing new opportunities to advance the next phase of miRNA-based therapeutics. While
proposed for NSCLC and prostate cancer, based on the utility of miR-34a for treating other cancers and
overexpression of the folate receptor alone on many epithelial cancers, including ovary, kidney, and colon
cancers, successful completion of this study could have far-reaching positive consequences.

Public health relevance
PROJECT NARRATIVE The project is relevant to the NIH’s mission and to public health because successful completion of this work will finally unveil the decade-long promise of using small RNAs as anti-cancer agents. Here we will generate small RNA delivery vehicles with exceptional specificity and improved pharmacokinetics along with a fully modified version of the notorious tumor suppressive microRNA, miR-34a. Coupling these second-generation ligands, that have enhanced circulation kinetics, with a stabilized version of miR-34a will finally allow for transitioning microRNAs successfully into the clinic, in this case for treating the top two most deadliest cancers – lung and prostate cancers.